CLINIC-RANDOMIZED TRIAL OF CLINICAL DECISION SUPPORT FOR OPIOID USE DISORDERS IN MEDICAL SETTINGS (CTN-0095). DSC5 CONTRACT. 09/20/2019 - 06/28/2024. N01DA-19-2250.

CLINIC-RANDOMIZED TRIAL OF CLINICAL DECISION SUPPORT FOR OPIOID USE DISORDERS IN MEDICAL SETTINGS (CTN-0095).